Longitudinal Resources for Genetic Research in Behavioral and Health Sciences

To provide genotyping services using GWAS Human OmniExpress on 9,466 experimental DNA Samples for the following study:Longitudinal Resources for Genetic Research in Behavioral and Health Sciences